Role of PAPP-A in Graves' Ophthalmopathy

PROJECT SUMMARY
Graves’ Ophthalmopathy (GO) is the most serious extra-thyroidal complication that develops in patients with
autoimmune Graves’ hyperthyroidism. It is characterized by increased orbital fat volume and extra-ocular
muscle within the unyielding bony orbit, which can have deleterious consequences on eye function. Orbital
decompression surgery is an effective but invasive treatment used for severe GO. A better understanding of
the pathological mechanisms underlying GO may identify novel targets to inhibit the development and
progression of GO before any clinical manifestation.
Insulin-like growth factor-I receptor (IGF-IR) signaling has been found to be essential in promoting GO
pathogenesis. A monoclonal antibody that binds to and blocks IGF-IR signaling, was recently FDA-approved
for treatment of GO. However, adverse events have been documented, all likely due to the ubiquitous nature of
IGF-IR. A better understanding of IGF signaling and its regulation in orbital tissue is needed to fully understand
mechanism and avoid/reduce off-target consequences. One approach would be to target modifiers of IGF-IR
signaling, instead of the IGF-IR per se. We propose PAPP-A as such a target.
PAPP-A is a novel zinc metalloprotease that can increase pericellular IGF bioavailability through cleavage of
inhibitory IGF binding proteins, in particular IGFBP-4. Conversely, inhibition of PAPP-A expression or its
proteolytic activity represents an innovative approach to decrease IGF availability with resultant attenuation of
IGF-IR signaling. Interestingly, the most potent stimulators of PAPP-A expression are pro-inflammatory
cytokines, which are increased in orbital tissue from GO patients.
We hypothesize that PAPP-A is a key modulator of IGF-R signaling in GO. Our Specific Aims are to:
1) Determine PAPP-A expression (basal and pro-inflammatory cytokine-induced) in orbital
fibroblasts from GO patients and control subjects.
2) Determine the effect of a neutralizing monoclonal antibody that specifically inhibits PAPP-A-
mediated IGFBP-4 proteolysis on IGF-I stimulated proliferation and differentiation in orbital
fibroblasts from GO patients.
We have primary fibroblasts from retro-orbital fat of GO patients at early passage in-hand and the experience
with culture and analyses to establish feasibility. Preliminary results support a role for PAPP-A in GO. We
anticipate outcomes from the proposed experiments that could ultimately lead to a novel targeted therapy for
patients with GO.

Public health relevance
PROJECT NARRATIVE Graves’ Ophthalmopathy (GO), the most serious extra-thyroidal complication that develops in patients with autoimmune Graves’ hyperthyroidism, is characterized by increased orbital fat volume and extra-ocular muscle within the unyielding bony orbit, which can have deleterious consequences on eye function. We hypothesize that a novel enzyme, PAPP-A, is a key regulator of GO, and will test this hypothesis using orbital fibroblasts from patients with GO. We anticipate that the results of our proposed experiments could ultimately lead to a novel targeted therapy for patients with GO.